Gene Ontology Consortium Supplemental

Project Summary The overall goal of the proposal is to perform extensive preliminary work that would ultimately lead to interoperability and to automatic data exchange between the GO and Reactome resources. We do not expect to fully achieve interoperability with a supplement, but, rather, the supplement will support the work needed to identify all the issues that need to be addressed, and to test solutions for these issues. The work proposed in this supplement will enable us to develop a detailed plan which would be necessary for future grant applications. In addition, based on an initial analysis that GO and Reactome have already performed together, we also expect substantial short-term benefits from the supplement: it will allow us to achieve interoperability for nearly all metabolic pathways (though not signaling pathways). For the broader genomics community, this work will result in a more fully interoperable set of major genomics resources and a model for coordination among resources to identify and share definitive sources of reference information for improved curation efficiency with minimal redundancy. Our work will utilize BioPAX-formatted data, thereby also enhancing interoperability of GO with any resource that utilizes BioPAX (these resources are integrated in PathwayCommons). This interoperability will also eventually make curation more efficient, as information curated in one project will greatly accelerate curation in other projects.

Public health relevance
PROJECT NARRATIVE Because of the staggering complexity of biological systems, biomedical research is becoming increasingly dependent on knowledge stored in a computable form. The Gene Ontology (GO) is by far the largest knowledgebase of how genes function, and has become a critical component of the computational infrastructure enabling the genomic revolution. It has become nearly indispensible in the interpretation of large- scale molecular measurements in biological research. Crucially, for human health research, GO is also one of a suite of complementary ontologies constructed in such as way to maximally promote interoperability and comparability of data sets. It represents the gene functions and biological processes that are perturbed in human disease, e.g. via the links from Human Phenotype Ontology (HPO) class abnormality of lipid metabolism, defined in relation to the GO class lipid metabolic process (GO_0006629), researchers or clinicians can find the set of genes that are known to be involved in this process. GO is a knowledge resource that can be statistically mined, either standalone or in combination with data from other knowledge resources, which enables experts to discover connections and form new hypotheses from the biological networks GO represents. All knowledge in GO is represented using semantic web technologies and so is amenable to computational integration and consistency checking. The proposed GO knowledge environment will enable a wider community of scientists to contribute to, and to utilize, a common, computable representation of biology. To ensure the knowledge environment meets the requirements of biomedical researchers, we will: a) deliver a comprehensive, detailed, computable knowledgebase of gene function, encoded in the Gene Ontology and annotations (computer-readable statements about the how specific genes function), focusing on human biology; b) provide a “hub” for a broad community of scientists to collaboratively extend, correct and improve the knowledgebase; c) ensure the GO knowledge resource is of the highest quality with regards to depth, breadth and accuracy; d) facilitate the transfer of insights obtained from studies of non-human organisms, such as the mouse and zebrafish, to human biology; and e) enable the scientific community to use the knowledgebase in analyses of large-scale genetic and -omics data. Our aims reflect the essential requirements for realizing the overarching objectives for a biomedical data resource: efficiently capturing and integrating biological knowledge and adhering to the highest possible standard for accuracy and detail; constructing and providing a robust, flexible, powerful, and extensible technological infrastructure available not only for internal use but just as easily by the wider community; and lastly, leveraging state-of-the-art social media, web services and other technologies to disseminate the GO resource to the entire biomedical research community.